Resource Core

ABSTRACT - RESOURCE CORE
The American Joint Replacement Registry (AJRR) is part of the American Academy of Orthopedic Surgeons
(AAOS) Registry Program, and is the Resource Core of the Mayo Core Center for Clinical Research in Total
Joint Arthroplasty (CORE-TJA). The AJRR currently captures about 25-30% of all hip and knee TJA
procedures in the United States. The AJRR will enhance the clinical research capabilities of the TJA research
community by providing access to nationwide registry data and implementing novel data collection and data
analysis methodologies to facilitate TJA research in large linked databases and clinical research networks. The
Specific Aims of the Resource Core are: (1) To work collaboratively with the CORE-TJA Methodology Core in
design, protocol development, statistical analysis and conduct of TJA studies using the AJRR datasets, (2) To
test the transportability and external validity of TJA-specific natural language processing (NLP) algorithms
(developed by Methodology Core) in hospitals within the AJRR network, and (3) To participate in pilot &
feasibility studies within the CORE-TJA network and to develop data and analytical standards for use of AJRR
data in partnership with academic institutions and clinical research networks. The availability of TJA-specific
data from the AJRR, enriched with linked databases and access to EHR data in clinical research networks will
offer tremendous research opportunities and exert a sustained, powerful influence on future TJA clinical
research landscape.

Public health relevance
NARRATIVE The Mayo Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA) will provide methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that will be addressed by the CORE-TJA include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.